Treating Maternal Depression in an Urban Community-Based Pediatric Asthma Clinic: Targeting Maternal Mood, Child Asthma Outcomes, and Health Disparities

PROJECT SUMMARY/ABSTRACT: This proposal details a 5-year plan to provide Dr. Rachel Margolis with the
knowledge and skills to become an independent clinical and translational researcher focused on promoting
health equity by improving pediatric asthma outcomes. Research Plan: Striking socioeconomic and racial/ethnic
disparities persist in pediatric asthma, particularly among under-resourced, Black children in urban settings.
Evidence demonstrates that structural and psychosocial risk factors contribute to these disparities. Maternal
depression is one prevalent and potentially modifiable risk factor. While there is evidence that treating maternal
depression may improve child health outcomes, mothers from under-resourced communities face significant
barriers to community-based treatment of depression. Integrated care (i.e., the delivery of mental health care
within the context of other ongoing medical care in a physical health care setting) offers an exciting and under-
explored option. It has been associated with reduced maternal depression and improved child health in pediatric
primary care. However, the feasibility, acceptability, and efficacy of embedding maternal depression treatment
into community-based pediatric asthma care needs to be demonstrated. Enhanced Brief Interpersonal
Psychotherapy (IPT-B) is a promising depression treatment for under-resourced mothers that has proven
efficacious among similar women in other settings, but it has not been studied within ongoing pediatric asthma
care. To maximize the success of Enhanced IPT-B in an asthma clinic setting, it is necessary to identify and
address potential mother and provider-level barriers to integrated depression care. Stakeholder engagement
with mothers and asthma clinic staff can facilitate the process of understanding and mitigating these barriers.
Thus, the overall goal of this proposal is to use stakeholder input to integrate and evaluate maternal depression
treatment in a community-based asthma clinic providing care to predominately under-resourced, Black children
with asthma. The Specific Aims are to: 1) Engage stakeholders in determining the most effective and acceptable
model for integrating Enhanced IPT-B for mothers into community-based pediatric asthma care; 2) Determine
the feasibility, acceptability, and preliminary efficacy of Enhanced IPT-B on decreasing maternal depressive
symptoms in a specific community-based pediatric asthma clinic through a pilot RCT; and 3) Determine the
preliminary efficacy of the intervention on improving child asthma care and health outcomes. Training Plan:
Through didactic coursework and mentored research experiences with her multidisciplinary team of
mentors/advisors, Dr. Margolis will develop advanced qualitative and mixed methods skills, learn clinical trial
design with a focus on behavioral interventions for under-resourced and racial/ethnic minority families, and gain
advanced implementation science skills. Dr. Margolis will emerge from her K01 training and research experience
as an independent behavioral scientist committed to enhancing health equity.

Public health relevance
PROJECT NARRATIVE There is increasing awareness that psychosocial factors contribute to the persistent racial/ethnic and socioeconomic disparities in pediatric asthma care and health outcomes despite the existing and highly effective NIH national guidelines for standardized care. Maternal depression is associated with poor pediatric asthma outcomes, and there is a need to examine if treating it, particularly when integrated within the context of ongoing pediatric asthma care, improves subsequent asthma management and health outcomes for under- resourced, urban, Black children. The proposed study fills this gap by studying the integration of Enhanced Brief Interpersonal Psychotherapy (a promising depression treatment for depression for mothers who are under-resourced) into ongoing community-based asthma care and evaluating its feasibility, acceptability, and preliminary efficacy on reducing maternal depression and child asthma morbidity and increasing health equity.